CORTICOSPINAL MECHANISMS FOR HIGH FAT DIET IMPEDING STROKE RECOVERY

SUMMARY / ABSTRACT
Comorbid metabolic conditions of stroke, including obesity and diabetes, worsen stroke injury and reduce the
capacity for stroke recovery. Given that stroke and these comorbid metabolic conditions are highly prevalent,
the goal of this project is to understand how their interactions mechanistically affect the corticospinal motor
system using high fat diet (HFD) as a model of metabolic disruption. In preliminary testing, HFD profoundly
worsens behavioral motor recovery after experimental stroke. HFD and experimental stroke also cause an
abnormal and profound emergence of lower extremity motor commands in areas of motor cortex that show little
of these commands in otherwise healthy conditions or with experimental stroke injury and control diet. These
abnormal lower extremity motor commands appear to be mechanistically due to increased synaptic signaling
within the corticospinal system at connections that have not been well identified in this pathway. Volitional skilled
motor control of the extremities is primarily achieved by the corticospinal tract and this pathway is often damaged
by stroke resulting in severe disability. The canonical view of the corticospinal tract is that it is a synaptic circuit,
from layer 5 pyramidal cells (L5PCs) in motor cortex, to spinal motor neurons that themselves signal skeletal
muscle (CST= L5PCs→ spinal motor neurons→ skeletal muscle). L5PCs that project to cervical spinal cord
(cervical-projecting) are thought to control upper extremity function whereas L5PCs that project to lumbar spinal
cord (lumbar-projecting) are thought to control lower extremity function. What is less known is whether single
L5PCs can innervate cervical and lumbar levels of spinal cord and thus contribute motor control to upper and
lower extremities. Similarly, it is recognized that L5PCs synapse on one-another (L5PCs→L5PCs) however it is
not known whether this is true between cervical-projecting L5PCs and lumbar-projecting L5PCs during stroke
recovery. Experiments here will test these seldom studied connections of the corticospinal system because they
may underpin the abnormal emergence of lower extremity motor commands that arise when HFD is combined
with experimental stroke. To investigate these hypotheses, we propose 3 aims: Aim 1. Determine whether
distribution and in vivo signaling of cervical- and lumbar-projecting L5PCs can support abnormal emergence of
hindlimb motor commands in anterior motor cortex when HFD is combined with experimental stroke. Aim 2. Test
whether physiology of cervical- and lumbar-projecting L5PCs can support abnormal emergence of hindlimb
motor commands in anterior motor cortex when HFD is combined with experimental stroke. Aim 3. Test timing,
duration and persistence of HFD to exacerbate upper and lower extremity deficits after experimental stroke
injury. This proposal aims to determine the corticospinal circuits responsible for this abnormal plasticity of lower
extremity motor control in order to guide its future targeted treatment as a novel therapy for stroke recovery in
the context of clinically-relevant comorbid metabolic conditions.

Public health relevance
PROJECT NARRATIVE Stroke injury and recovery are often made worse by comorbid metabolic conditions including obesity and diabetes yet there are few evidence-based stroke-treatments that address these interactions. Testing of experimental stroke here has identified a novel synaptic mechanism of the corticospinal motor pathway that may underpin comorbid metabolic conditions impeding stroke recovery. This proposal aims to fully understand this synaptic mechanism in order to guide its future targeted treatment as a novel therapy for stroke recovery in the context of clinically- relevant comorbid metabolic conditions.